Developing a blood fatty acid-based algorithm as an early predictor of insulin resistance: Applying machine learning to harmonized data from prospective cohort studies

Project Summary Metabolic diseases, such as Metabolic Syndrome (MetSyn) and type 2 diabetes (T2DM)
affect ~37% and ~10% of Americans, respectively, with a substantial impact on the health, quality of life and
financial security of these individuals. Without the means to identify high risk individuals conveniently and
cheaply, many will find care too little and too late: more than 80% of individuals with pre-diabetes don’t know
they have it. Thus, there is a need for accessible and inexpensive early predictive biomarkers of MetSyn and/or
T2DM to facilitate the early identification of high-risk individuals, providing the time necessary to make
meaningful lifestyle changes to slow or prevent disease progression. Hemoglobin A1C (HbA1c) and fasting
plasma glucose are traditional markers of hyperglycemia and insulin resistance, however, these markers have
significant limitations in that they are measures of existing, not impending, disease. Other tests of insulin
resistance (e.g., oral glucose tolerance tests and hyperinsulinemic euglycemic clamps) are inefficient,
cumbersome for the patient, and expensive; thus, they are also not viable options as early screening tools.
Emerging evidence suggests that erythrocyte (RBC) fatty acid (FAs) profiles may serve as an early signal of
impending hyperglycemia up to 5 years before T2DM develops regardless of whether insulin sensitivity, insulin
secretion and glycemic status are known. As a clinical laboratory that specializes in providing FA
measurements, interpretation and customized behavioral interventions, OmegaQuant Analytics (OQA)
supports a large and growing customer base of researchers, clinicians, businesses, and individuals. OQA has
measured full FA profiles (28 FAs) on numerous randomized clinical trials and prospective cohort studies.
Furthermore, OQA is a leader in the at-home FA testing market through its innovative dried blood spot
collection system, testing almost 40,000 samples annually. Through a partnership with the Fatty Acid Research
Institute (FA expertise; biostatistical support; data access), we propose to develop highly predictive metabolic
indices from FA profiles using an innovative approach leveraging existing prospective cohort data. We will do
this by (Aim 1) predicting future MetSyn or T2DM status from an RBC FA signature using a harmonized
dataset from five leading prospective cohort studies yielding a sample of 10,264 individuals (including 1,173
minorities). Prospective statistical predictions using the harmonized data sets will yield the FA Metabolic Index
(FAMI) and FA Diabetes Index (FADI). We will then (Aim 2) explore how FAMI and FADI can be leveraged to
profitability by creating interpretative reports for FAMI and FADI, providing an understanding and actionable set
of steps to change dietary behaviors to modify MetSyn/T2DM risk and exploring willingness of clinicians,
laboratories and individuals to purchase the tests. These two simple, early-warning tests will allow for targeted
intervention of individuals at high-risk for developing MetSyn and/or T2DM, ultimately leading to substantial
reductions in the prevalence and societal burden of this disease.

Public health relevance
Project Narrative Early identification of patients at risk for developing metabolic syndrome (MetSyn) is urgently needed so that preventive measures can be instituted early. We propose to develop and validate a blood fatty acid profile to identify disordered fatty acid patterns predictive of the development of MetSyn (and ultimately type 2 diabetes mellitus, T2DM) using existing data from 5 well-respected US cohort studies. Our ultimate goal is to market a blood fatty acid profile which, either alone or in combination with other risk factors, improves the prediction of impending MetSyn and T2DM.